Clinical Core

PROJECT SUMMARY - Clinical Core (CC)
The mission of the UC Davis Alzheimer’s Disease Research Center (UCD ADRC) is to advance the science of
healthy brain aging among diverse populations while caring for those affected by dementia. This mission and
the work of the Clinical Core (CC) contribute to many of the milestones and goals set forth by the National
Alzheimer’s Disease Plan (NAPA). The CC is essential to the UCD ADRC’s mission, in part, by maintaining the
Longitudinal Diversity Cohort (LDC), a large, highly diverse group of older adults followed annually through
autopsy, and by overseeing the collection of the multiple sources of data obtained from these individuals. This
cohort is highly unique among ADRCs in that it includes substantial numbers of older adults from two of the
largest underrepresented groups in the U.S.: African Americans (~25% of the cohort) and Hispanics (~25%).
This diversity translates into heterogeneity of cognitive trajectories, incident Alzheimer’s disease and related
dementias (ADRD), risk factors and lifecourse experiences, and the prevalence of vascular risk factors
consistent with community populations, thereby providing a valuable resource for studying both AD and mixed
pathologies. The sample is similarly diverse in terms of education (range of 0-20 years), native language,
socioeconomic and immigration status, and exposure to adversity. Through primarily community recruitment,
the UCD ADRC enrolls cognitively normal and mildly impaired individuals to study cognitive decline and the
transition to various stages of disease. This facilitates identification of novel modifiable risk and protective
factors and biomarker development, both of which have implications for dementia prevention. All individuals in
the LDC are characterized at an uncommonly rich level (well beyond the UDS) that includes neuroimaging and
blood biomarkers, annual diagnostic classification, psychometrically rigorous measurement of cognition and
daily function (separate from measurements used for diagnosis) and extensive collection of lifecourse
sociocultural and behavioral data. The LDC is a well established cohort with extensive data from both active
(n=425) and inactive cases (n>950), some with 15+ years of follow-up. All of this data has been integrated into
the UCD ADRC database that provides an easily accessible research resource widely utilized by researchers
both within and outside of our Center. Data from the LDC has contributed to innovative new research findings
in many areas including enhancing our understanding of ethnic/racial disparities in cognitive aging and the
contributions of vascular disease to brain health, among many other contributions. In addition, the CC has the
added advantage of creating bi-directional translational relationships with epidemiological studies aimed at
understanding the complex determinants of ADRD and accelerating the development of effective treatment
and prevention across the ADRD spectrum.